Antimicrobial, anti-inflammatory, analgesic, silver-based, electrospun bandages for superior wound healing

PROJECT SUMMARY/ABSTRACT This project aims to develop the ideal bandage that provides antimicrobial, anti-­inflammatory and analgesic activity locally to the site of wounds infected with biofilms of multi-­drug resistant Pseudomonas aeruginosa, listed as a serious threat by the Centers for Disease Control and Prevention. Ibuprofen delivered locally to wounds has been shown to act both as an anti-­inflammatory and an analgesic. Silver has been incorporated into commercially available wound dressings due to its potent, broad spectrum antimicrobial activity, although the high local concentrations impede wound healing through toxicity to human cells. Preliminary data demonstrate potent antimicrobial and anti-­inflammatory activity of a novel silver salt of ibuprofen (Ag+IBU) that will be loaded into electrospun scaffolds of the Food and Drug Administration (FDA)-­approved polymer, poly(caprolactone) (PCL) functionalized with collagen to promote wound healing. N-­acetyl cysteine (NAC), an FDA-­approved therapeutic that abrogates silver toxicity will also be loaded into the PCL membranes. The project addresses the hypotheses that electrospun PCL membranes functionalized with collagen and loaded with Ag+IBU and NAC will provide superior antimicrobial and wound healing efficacy compared with a commercially-­available silver-­based bandage. The following aims will address these hypotheses: 1. fabricate and evaluate the capacity of Ag+IBU/NAC-­loaded, collagen-­functionalized PCL scaffolds to enhance cell adhesion and migration, eradicate P. aeruginosa biofilms, and preserve fibroblasts, in vitro, and 2. determine the localized therapeutic concentrations, wound healing ability, and antimicrobial activity of Ag+IBU/NAC-­ loaded, collagen-­functionalized PCL scaffolds compared with free drug and commercially available Ag+ loaded bandages, in vivo. These studies will be the first to use N-­acetyl cysteine to abrogate silver toxicity and the first to assess the wound healing activity of bandages loaded with the novel antimicrobial, anti-­inflammatory, and analgesic small molecule, silver ibuprofen.

Public health relevance
PROJECT NARRATIVE The goal of this project is to develop the ideal bandage that provides antimicrobial, anti- inflammatory and analgesic activity locally to the site of wounds infected with biofilms of multi- drug resistant Pseudomonas aeruginosa. Ibuprofen delivered locally to wounds has been shown to act both as an anti- inflammatory and an analgesic. Silver has been incorporated into commercially available wound dressings due to its potent, broad spectrum antimicrobial activity, although the high local concentrations impede wound healing through toxicity to human cells. A novel silver salt of ibuprofen will be co- loaded into electrospun scaffolds with N- acetyl cysteine, an FDA- approved therapeutic that abrogates silver toxicity, and the wound healing properties compared with commercially available silver- loaded bandages.